Personalized anesthetic brain monitoring: Developing novel systems, sensors, and algorithms for aging, dementia, and Alzheimers disease patients

PROJECT SUMMARY
In the United States, nearly 100,000 patients receive general anesthesia and sedation daily to safely undergo
surgical and non-surgical procedures. A high proportion of these patients are older than 65 years of age. These
older patients are at higher risk of post-operative delirium and cognitive dysfunction. Many of these older patients
have dementia, including mild cognitive impairment or Alzheimer’s disease, further elevating their risk of POD
and POCD. Anesthesiologists are familiar with how to adjust anesthetic management to account for changes in
systemic physiology in older patients, e.g., blood pressure, heart rate, or respiration. Unfortunately, with existing
technologies, anesthesiologists have no physiologically principled way to account for age-dependent changes
in the brain’s response to anesthetic drugs. Today’s anesthetic brain monitors were developed in the 1990’s
and do not account for recently-described age-dependent changes in brain activity during anesthesia. When
these now outdated monitors are used, older patients are up to 10-times more likely to receive more anesthesia
than necessary to maintain unconscious. In short, currently available anesthetic brain monitors are based on
outdated science and technology and predispose older patients to unnecessarily high anesthetic exposures.
The consequences for older patients and patients with dementia and/or Alzheimer’s disease can be significant,
since increased anesthetic exposure is associated with increased incidence of delirium, post-operative cognitive
dysfunction, and even mortality. PASCALL Systems, Inc. proposes to develop novel systems and personalized
algorithms to monitor aging, dementia, and Alzheimer’s disease patients during general anesthesia and sedation.

Public health relevance
PROJECT NARRATIVE A large proportion of patients receiving general anesthesia or sedation are older than 65 years of age and many may have Alzheimer’s disease and related dementias, but existing brain monitoring technologies do not account for age-dependent changes in the brain’s response to anesthetic drugs. This proposal seeks to develop personalized anesthetic brain monitoring for aging, dementia, and Alzheimer’s disease patients receiving general anesthesia and sedation.